EVALUATION OF HORMONAL CHANGES OF ABNORMAL PUBERTY

This study is designed to evaluate the mechanisms involved in delayed and precocious puberty. Dynamic evaluation of the different components of the hypothalamic, pituitary, gonadal, and adrenal systems will provide a rational approach for the treatment of abnormal puberty.